Biomarkers of ischemic brain injury in adults with sickle cell disease

PROJECT SUMMARY
Sickle cell anemia (SCA) is a chronic hemolytic anemia that dramatically increases the risk of central nervous
system complications including silent cerebral infarcts (SCI), overt strokes, and intracranial stenosis. Stroke risk
screening procedures for adults with SCA are considerably underdeveloped compared to procedures for children
with SCA and other populations of adults at risk for stroke. However, SCI and overt stroke risk persists across
the lifespan, and SCIs occur in more than 50% of adults with SCA by age 30 years, representing a frequent
cause of long-term disability. The absence of an approach to identify adults at risk for new or recurrent cerebral
infarcts is a major limitation in adult SCA care, as treatments for SCA continue to improve and lifespan is
increasing. The critical barrier to addressing stroke risk and prevention in adults rests with our inability to identify
underlying brain tissue-level impairment as a part of routine medical care and our need to develop new screening
tools to triage adults with SCA for appropriate stroke prevention therapies. The overall goal of this work is to
utilize recently identified biomarkers of inadequate cerebral hemodynamic compensatory mechanisms to test
fundamental hypotheses about stroke risk and treatment response in adults with SCA in a longitudinal study.
Over the past seven years, we have established a multidisciplinary team to systematically evaluate adults with
SCA, assessing known stroke risk factors in sequence with more novel pathophysiological indicators including:
(i) oxygen extraction fraction (OEF; ratio of oxygen consumed to oxygen delivered), (ii) cerebral blood flow (CBF;
rate of blood delivery to tissue), (iii) flow velocity, and (iv) cerebrovascular reactivity (CVR; ability of arterioles to
respond to a vasoactive challenge). This work led to the findings that (i) OEF is elevated in adults with SCA and
clinical impairment (prior stroke, intracranial stenosis, or monthly transfusions), (ii) OEF is elevated in adults with
SCA and evidence of new or progressive infarcts (retrospective data), and (iii) CBF response to treatment with
blood transfusion appears to be less robust in adults than children with SCA. We have developed methods to
measure these hypothesized stroke risk biomarkers using MRI approaches that do not require exogenous
contrast agents, making them a possible tool for SCI surveillance and for evaluating treatment response. Here,
we propose to extend this work to (Aim 1) a longitudinal, prospective study, to evaluate how metabolic and
hemodynamic stroke risk factors can be used to identify which adults with SCA will have new infarcts; (Aim 2) to
quantify the impact of stem cell transplant, an emerging curative treatment, on brain tissue health; and (Aim 3)
to compare OEF values obtained from the two most popular non-invasive MRI methods thereby informing their
collective or individual use in future multi-site clinical trials. The long-term goal is to identify underlying brain
tissue-level impairment that may provide evidence-based biomarkers to assess stroke risk, treatment response,
and guide therapy decisions in adults with SCA, with the goal of reducing stroke and cognitive dysfunction in this
high-risk population for which validated stroke screening tools do not exist.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE In contrast to children with sickle cell anemia (SCA) in whom stroke prevention screening has been highly successful, methods to identify adults with SCA at highest risk of new or recurrent stroke have not been developed and are urgently needed. This study uses multiple novel brain imaging techniques to measure differences in brain oxygen consumption, brain blood flow, and brain structure in adults with SCA that progress to develop new strokes, and also to understand how these methods can be used to evaluate the effect of curative SCA treatments on brain health. Study findings are intended to improve stroke risk assessment and allow individualized care to eventually prevent strokes in adults with SCA.